Endoplasmic Chaperone GRP78 Interacts with DMP1 to Function in Biomineralization

PROJECT SUMMARY: Glucose regulated protein-78 (GRP78) is a dynamic endoplasmic reticulum chaperone of the heat shock family that is involved in the unfolded protein and cellular stress response. GRP78 and other GRPs are known to bind Ca2+ in the ER to modulate the levels of calcium in the cell and respond to ER stress. We have demonstrated earlier that GRP78 is expressed by osteoblasts and odontoblasts and localized in the mineralized matrices of bone and dentin. Interestingly, GRP78 functions as a receptor for dentin matrix protein 1 (DMP1), a key protein involved in matrix mineralization. In this proposal, we will explore the synergistic function of GRP78 and DMP1 during mineralization. Previous studies demonstrate that upon stress, GRP78 can translocate from the ER to the cell surface. Additionally, our lab showed that GRP78 is a receptor for DMP1. We aim to understand how GRP78 interacts with DMP1 to promote osteogenic differentiation and matrix mineralization in periodontal ligament stem cells; moreover, we will determine the mechanism of GRP78-DMP1 complex internalization and subsequent translocation intracellularly to aid in cell differentiation through in vitro cell culture work. Through an in vivo mouse model, we will determine the functional significance of GRP78 in mineralization with periodontal ligament stem cells. Overall, our overarching goal will be to determine GRP78’s functional significance in mineralization to ultimately provide a novel way to achieve bone regeneration in the periodontium.

Public health relevance
PROJECT NARRATIVE: This study aims to understand the interaction of Dentin Matrix Protein-1 (DMP1) and Glucose Regulated Protein-78 (GRP78) and how they function in the differentiation periodontal ligament stem cells and in mineralization. We will gain insight into how ER stress influences the interactions of DMP1 and GRP78 on PDLSCs and how it alters their biochemistry, architecture, and molecular interactions. This knowledge will give us a deeper understanding of biomineralization and lead to more reliable and effect ways of tissue regeneration.